Tobacco use trajectories and related mechanisms among US adults and youth representing minority and intersecting minority identities

SUMMARY/ABSTRACT
Tobacco-related disparities are well-documented, particularly among racial/ethnic minorities, sexual/gender
minorities (SGM), low socioeconomic status (SES; e.g., low income), and rural populations. However, the
literature is limited by insufficient examination of: 1) such disparities among those with intersecting minority
identities; 2) disparities in use of the diverse tobacco products in the current tobacco market; 3) mechanisms
(e.g., marketing exposure, differing product perceptions) underlying such disparities among those with minority
and intersecting minority identities; and 4) longitudinal associations, particularly using nationally-representative
data. Regarding the former, groups disproportionately impacted are typically described by social identifiers that
are visible and relatively static, like race. However, social determinants (e.g., industry marketing) impact
individuals and may have multiplicative effects, thus requiring a more nuanced understanding of the mechanisms
by which certain groups are impacted. Informed by social determinants of health (SDOH) and intersectionality
perspectives, this study’s objective is to test our central hypothesis that US adults and youth representing
intersecting minority identities will demonstrate distinct tobacco use behaviors (e.g., likelihood of use vs. no use
of distinct products, polyproduct use profiles) and related mechanisms (e.g., marketing exposure and
perceptions) over time. The rationale is that certain products may have specific characteristics (e.g., novelty,
technology, flavors) that appeal to and/or are marketed toward different subgroups (i.e., minorities) and thus
shape their perceptions (e.g., risk, social norms) and use behaviors. Moreover, individuals representing more
than one targeted subgroup may be particularly impacted. We will use the Population Assessment of Tobacco
and Health (PATH) study (both adult and youth survey data) – a nationally-representative longitudinal cohort
study – to examine: 1) differences in tobacco use behaviors over time (i.e., trajectories in use of different
products, any product, or multiple products; use of flavored products) among adults representing specific minority
identities (i.e., racial/ethnic minorities, SGM, low-SES, rural) and explore the effects of intersecting minority
identities (i.e., intersectionality) on use behaviors; 2) pathways underlying differential tobacco use behaviors over
time among adults representing minority and intersecting minority identities, including tobacco marketing
exposure and product perceptions (i.e., risks, social norms); and 3) differences in marketing exposure and
product perceptions over time as outcomes – and as mechanisms of use to the extent possible (due to lower
youth use prevalence) – in youth of minority and intersecting minority identities. This proposal will advance our
long-term goal of informing research, interventions, and regulations to catalyze the reduction of tobacco-related
disparities and the population impact of tobacco in the US.

Public health relevance
PROJECT NARRATIVE Tobacco-related disparities in key groups (i.e., racial/ethnic minorities, sexual/gender minorities, low socio- economic status groups, rural populations) are well-documented; however, there has been limited examination of: 1) disparities among those with intersecting minority identities; 2) disparities in use of the diverse tobacco products in the current market; 3) mechanisms of such disparities among those with minority and intersecting minority identities; and 4) longitudinal associations, particularly using nationally-representative data. This study will examine differences in tobacco use behaviors (e.g., use of distinct products, multiple product use) and mechanisms (e.g., marketing exposure, product perceptions) over time among US adults and youth representing disproportionally-impacted groups and their intersections. This proposal will inform: 1) research with more detailed assessment of key disparity-related factors among intersecting minority subgroups to further elucidate such phenomena; and 2) regulations and interventions to reduce tobacco-related disparities.